T lymphocyte bystander responses in male-biased myocarditis

Project Summary/Abstract
Myocarditis, which is inflammation of the heart muscle mediated by immune cell infiltration and tissue damage,
can lead to cardiac dysfunction or sudden death. The most common cause of myocarditis is viral infection,
followed by other triggers including mRNA vaccination. Myocarditis, including after viral infection and vaccination,
is more frequently seen in males, yet underlying mechanisms remain incompletely understood. A clearer
understanding of male-biased myocarditis is essential for improving disease management and optimizing
vaccine development. Previous work by us and others demonstrated that relative to healthy vaccinated controls,
mRNA vaccine-associated myocarditis patients have elevations in circulating cytokines like IL-15, which
activates T cells and innate-like bystander responses, coupled with increased peripheral activated cytotoxic T
cells upregulating chemokine receptors, including CXCR3 and CCR5, implicated in heart tissue infiltration and
site-specific bystander activation. In T cell bystander activation, memory T cells undergo nonspecific activation
mainly via cytokines like IL-15 without TCR signaling or antigen recognition. Histopathological examination of
patient heart biopsies confirmed predominant T cell infiltration. These immune responses have similarly been
implicated in viral myocarditis, suggesting a potentially key role in male-biased heart inflammation. In preliminary
studies, “dirty” mice with diverse prior microbial exposures and memory immune populations are shown to better
model T cell bystander activation. Further, IL-15 administration in vivo, mimicking systemic triggers of pathology,
induces male-biased bystander T cell responses and effects consistent with findings seen in myocarditis, which
are reduced after androgen receptor blockade. Consistently, heart cytotoxic T cells were found to have elevated
expression of the androgen receptor relative to various other tissues and immune subsets, with enhancing effects
of androgens on heart bystander T cell activation signatures, which could explain the male bias and heart
specificity. Based on this accumulating evidence, my hypothesis is that IL-15-induced bystander cytotoxic T cell
responses mediate male-biased heart inflammation in an androgen-enhanced manner. To test this hypothesis,
Aim 1 will define the role of IL-15-induced bystander T cells in male-biased heart inflammation using the
developed dirty mouse in vivo system. Aim 2 will use androgen deprivation and supplementation to test effects
on male-biased heart inflammation in vivo, including by multiplexed immunofluorescence spatial imaging. This
study will advance our understanding of male-biased myocarditis and illuminate novel translational insights into
sex immune differences and T cell bystander responses, both of which are widespread across numerous
immune-mediated diseases. During this work, I will continue honing a unique skill set combining experimental
techniques with powerful computational and bioinformatic approaches in an exceptional training and research
environment toward a career advancing clinically relevant immunology as a physician-scientist.

Public health relevance
Project Narrative Immune-mediated heart muscle inflammation (myocarditis) can occur after viral infections or more rarely vaccination, which is much more frequent in males, yet the immune drivers of this pathology and sex bias remain incompletely understood. Previous work has implicated a potential role for T cells and related responses activated by inflammatory triggers in susceptible individuals. By investigating effects from inflammatory signals on T cells as well as male androgens in male-biased heart inflammation using cutting-edge technologies, this study can inform disease management and vaccine development to improve patient clinical care as well as reveal fundamental insights into immune processes implicated across a wide range of other diseases.